Convergent Drivers of Tumor Evolution at the Mitotic Spindle

Clear cell renal cell carcinoma (ccRCC) is characterized by two major chromosome abnormalities, loss of 3p
and gain of 5q, which occur nearly universally in this disease. Here we focus on the unique insights these defects
provide into activities at the nexus of chromatin and cytoskeletal biology: coordinated activity of chromatin
remodelers on spindle microtubules needed for the integrity of mitosis. Colocalized on chromosome 3p
are the chromatin remodelers SETD2, PBRM1, and BAP1 and the E3 ligase VHL. Our groups together have
pioneered the concept that SETD2 and PBRM1 have active roles on the cytoskeleton that regulate mitotic fidelity,
with impacts on genomic integrity that are only now being revealed. SETD2 is a methyltransferase for both
histones and spindle microtubules. Using mutant alleles, we isolated loss of microtubule methylation as
underlying the genomic instability tied to SETD2 loss. We further discovered that PBRM1, a substrate
recognition member of the PBAF chromatin remodeler, specifically recognizes the SETD2 methyl mark on
microtubules, and like the mark it “reads”, is required for genomic stability. Finally, we identified the mitotic
kinase AURKA as a new target for VHL-mediated degradation, linking this canonical protein (VHL) to complex
regulation of mitotic spindle assembly in ccRCC. In Preliminary Data, we find in addition to VHL loss stabilizing
AURKA, AURKA regulates SETD2 via phosphorylation on S2080, connecting VHL and SETD2 for the first time
in a common oncogenic pathway. We have also discovered another chromatin remodeler, the chromosome 5q
histone methyltransferase NSD1, is also acting at the spindle, and excitingly scores in a CRISPR synthetic
lethality screen with SETD2 loss.
Our Overarching Hypothesis for this application is that VHL and RCC-associated 3p and 5q chromatin
remodelers coordinately regulate methylation of spindle microtubules to maintain genomic stability,
which when defective, offers unique opportunities for therapeutic intervention. To address our
Overarching Hypothesis, we offer three Specific Aims: We will 1) dissect the convergence on the mitotic spindle
of 3p and 5q ccRCC chromatin remodelers, 2) define the features of their interactions at the molecular and
biochemical levels that promote mitotic integrity or failure, and 3) mechanistically evaluate points of intervention
that lend insight into the controls governing mitotic spindle integrity. To accomplish these aims, we will use
innovative tools and strategies that precisely evaluate combinatorial mono- and bi-allelic loss of 3p and 5q genes
that occur during progression of ccRCC, as well as a rich pipeline of primary ccRCC organoids.
The classic genomic features of ccRCC provide new insights on how cytoskeletal activities of chromatin
remodelers converge to maintain genomic stability, the principles of study are broadly applicable to many other
cancers and have important ramifications for the development of targeted therapies for this disease.

Public health relevance
A triumvirate of interacting regulatory elements co-exist on chromosome 3, which is commonly lost in human clear cell renal cell carcinoma, contributing to haploinsufficiency, with loss of heterozygosity driving disease progression. This study will explore the unique interplay between these factors (methylation writers, readers, and erasers) at the mitotic spindle that sets the stage for renal carcinogenesis. We further identify and define key nodes at which pharmacologic strategies provide the opportunity to explore therapeutic intervention.